Imaging-based biomechanical assessment of abdominal aortic aneurysms for improved progression risk prediction

Dr Leach is an early career physician-scientist with specialty training in radiology and computational
biomechanics, who seeks to continue developing his career within the VA health care system. Dr Leach’s
long-term career goal is to use all of his clinical and research knowledge and expertise to
comprehensively help patients and clinicians maximize wellbeing and prevent and alleviate suffering
through improved understanding, diagnosis, and risk stratification of vascular diseases. To achieve
this, Dr Leach seeks additional mentored training to further develop his knowledge and expertise in two key
ways: 1) advancement of his scientific skills in imaging-based analysis of vascular disease that steps beyond
anatomic characterization, to include compositional analysis, biomechanics, and biological features extracted
from advanced imaging, and 2) leadership in clinical radiology and the vascular imaging research community.
Improving management of abdominal aortic aneurysms (AAA) at both the patient and health care
system levels necessitates new capabilities to distinguish aneurysms that will remain stable and clinically
quiescent from those that will rapidly progressively enlarge and possibly rupture. To do this, we must step
beyond the present paradigm of AAA surveillance, which involves no more than measuring the aneurysm size,
and find ways to assess other AAA features that predispose to rapid progression. Dr Leach is perfectly
positioned to pursue development of powerful new methods of AAA assessment, owing to his advanced
scientific training and intimate familiarity with the complexity of AAA disease, its clinical management, and the
simultaneous shortcomings of current imaging evaluation and impressive possibilities for future development.
In this application, Dr Leach aims to combine his clinical expertise in vascular radiology and technical
expertise in imaging-based biomechanical analysis of blood vessels to perform the necessary developments
that will permit increasingly patient-specific geometric and biomechanical AAA analysis (Aims 1 and 2),
multiparametric and multi-timepoint evaluation of AAA, and will culminate in a hypothesis-driven investigation
of AAA features and their associations with aneurysm progression (Aim 3). [[Central to this work is careful
testing and benchmarking of advanced MRI-based methods against the de facto standard CT-based methods
of AAA assessment, to determine the appropriate balance between sophistication and precision and wide
availability and cost.]] Dr Leach’s pursuit of these advancements necessitates close interaction with the
community of radiologists and imaging researchers, vascular surgeons, and computer scientists at the VA, and
provides a natural opportunity for Dr Leach to expand his leadership within that community.
The proposed research and career development plan is expected to meaningfully advance our ability to
comprehensively assess the progression risk of AAAs on a patient-specific basis and prepare Dr Leach for
leadership roles in the vascular imaging and vascular research domains. To facilitate success in the scientific
and training aspects of the proposal, Dr Leach has assembled an exceptional team of mentors and advisors
who are themselves respected leaders in vascular imaging (Hope, Saloner), image processing and
computational analysis (Mitsouras), [[and cardiovascular surgery (Gasper, Tseng)]]. Dr Leach’s training plan
consists of directly mentored experiences, formal coursework and workshops, and structured counseling from
advisors. The research and training components of this proposal will collectively equip and establish Dr Leach
as a capable independent investigator well-positioned to submit a Merit Review application in the later years of
the CDA period. [[Dr Leach is committed to advancing the care of veterans and others with vascular disease,
and through the proposed research and training, he will build a research program at the VA toward this goal.]]

Public health relevance
Abdominal aortic aneurysms (AAA) are reported in up to 8% of men 65 or older, and are associated with smoking, atherosclerosis, and hypertension, making AAA highly relevant to our veteran population. Because AAAs are commonly fatal when they enlarge to the point of rupture, patients undergo periodic imaging surveillance to assess aneurysm size and retrospectively estimate progression. We currently have no reliable way to prospectively identify the subset of AAAs predisposed to rapid progression with attendant increase in rupture risk. We propose to improve imaging-based assessment of AAA, incorporating patient-specific biomechanical analysis to prospectively estimate AAA progression risk. This work will contribute to a new ability to tailor imaging surveillance protocols to individual patients based on more than just aneurysm diameter, and may set the stage for an improved calculus of determining if and when AAA intervention is warranted.